Chemical glycobiology tools to decipher host-microbiota interactions

PROJECT SUMMARY
The microbes that live in and on our bodies—our microbiota—represent an emerging ﬁeld for precision medicine
and personalized care. Microbiota composition varies signiﬁcantly between individuals, with over 4,500 different
species represented across broad human metagenomic analyses. This variety of species appears to have
functional consequences, and correlative studies have associated speciﬁc microbes with better outcomes for
multiple immune-related diseases, including cardiovascular disease, neurological disorders, and many cancers.
However, translating these ﬁndings into microbiota-targeted medicines has been largely limited by the signiﬁcant
lack of mechanistic data that underlie these associations. In this New Innovator Award proposal, we will tackle
this critical gap in knowledge by discovering precise molecular, cellular, and spatial factors that allow commensal
and so-called “probiotic” microbes to modulate host immunity. Here, we will focus on exo- and capsular
polysaccharides, which are well-known modulators of both innate and adaptive immunity. Although glycan
extracts from multiple microbial isolates have been implicated to alter inﬂammatory signaling, polysaccharides
remain incredibly difﬁcult to characterize compared to other biopolymers due to a lack of high-throughput and
generalizable tools. Moreover, microbial polysaccharides pose an incredible challenge for current strategies
used to study mammalian glycans due to the sheer diversity of glycan composition, structure, and localization
found even across closely related microbial isolates. Our proposal will address this major technical challenge
through the development of diversity-oriented approaches that will directly identify the host receptors, glycan
motifs, cell types, and gut regions that are involved in microbial glycan signaling to the host. These goals will be
achieved through new techniques to (1) screen glycome-receptorome interactions, (2) generate libraries of
homogeneous and multipurpose glycan probes, and (3) engineer functionality into the microbial glycocalyx. As
validation, we will then use our approaches to (4) illuminate the molecular mechanism(s) by which structurally
disparate polysaccharides can act as novel ligands for a well-known pattern recognition receptor. Together, the
strategies of our innovative proposal will provide a new molecular roadmap that reveals how microbial glycans
mediate pro- and anti-inﬂammatory signaling in the gut and beyond. The methods generated by this proposal
will also be generalizable to other polysaccharides found in pathogenic bacteria and even those from other
kingdoms of life, expanding our arsenal of tools in chemical glycobiology to better characterize fundamental
principles of glycan signaling.

Public health relevance
PROJECT NARRATIVE Although the human microbiota has been broadly associated with improved outcomes for multiple diseases, the development of microbiota-targeted medicines has remained largely stalled due to a lack of mechanistic information that underlie these correlations. In this project, we will develop a suite of chemical tools to discover and characterize physical interactions between microbiota, their glycan metabolites, and mammalian tissues. The proposed research will illuminate structure-function relationships that underlie microbiota-mediated signaling, which may better guide approaches to deploy and even prescribe probiotic and postbiotic biotherapeutics to ameliorate inﬂammatory diseases.